HLA, ABO, AND B-CELL ALLOANTIGENS AND OCULAR INFLAMMATORY DISEASE

Patients with ocular toxoplasmosis, pars planitis, Behcet's disease, chorioretinitis of unknown origin, are being studied to determine the phenotype frequency of the HLA, ABO, and B-cell alloantigens. Because the B-cell alloantigens or DR antigens are thought to play a role in the immunologic response to antigens, these findings will complement other immune uveitis studies being simultaneously carried out. Restriction fragment analysis has begun to complement these HLA studies.